SIX MONTH PHASE II TRIAL OF PIOGLITAZONE GROUP IN NIDDM PATIENTS

The objective of this study is to assess the efficacy and safety of 7.5, 15, 30 and 45mg given daily for 26 weeks of an oral hypoglycemic agent (pioglitazone) in achieving glycemic control in non-insulin-dependent diabetes (NIDDM) patient as compared to a matching placebo group.